IN VIVO DETERMINATION OF STABILITY OF STANDARDIZED GRASS EXTRACTS

Proposed FDA reference grass extracts of Bermuda, june, orchard, perennial rye, sweet vernal, and timothy were evaluated for stability when diluted with HSA-saline diluent and stored continuously at 2-8~C for up to 1 year. The dilution factor for each grass ranged from 1: 1.5 millionth to 1:22.5 millionth. Relative potency of the stored extract was determined with respect to a freshly reconstituted reference using parallel line skin test assay. All grass extracts were equipotent to a freshly reconstituted reference for up to 1 year except for timothy which was equipotent to its reference for up to 3 months, but fell below the 95% lower limit of potency at 1 year. These data indicate that highly diluted standardized grass extracts remain stable for months when diluted with HSA diluent and stored continuously at 2- 8 C. Additional stability data using subjects reactive to heat labile grass allergens are proposed.